Prevalence and persistence of the ETV6/RUNX1 pre-leukemic clone

Abstract
Leukemia is the most common childhood cancer and represents approximately one third of all cancer diagnoses
among children age 0-14. There is strong evidence that acute lymphoblastic leukemia (ALL), the most common
type of leukemia in children, is initiated in utero. The ETV6/RUNX1 gene fusion, which is considered an early
initiating event in the development of ALL, is present at birth in some children who later develop ALL. Children
born with these leukemia-specific translocation in blood cells have pre-leukemia, and there is a need to define
the epidemiology of pre-leukemia and identify the factors that contribute to pre-leukemia persistence and
progression to ALL. We have developed a robust new method for detection of ETV6/RUNX1 pre-leukemia which
uses newborn blood spots. We propose to use this method to: 1) examine the newborn blood spots of 500
children who later developed leukemia and from 3000 healthy children who did not develop leukemia to identify
the determinants of pre-leukemia at birth; 2) estimate the risk of childhood ALL given pre-leukemia at birth; and
3) evaluate how long pre-leukemia persists in childhood using both newborn blood spots and, from the same
cohort of children, blood samples collected over time within early childhood. Together, these goals will allow us
to determine how many children with ALL are born with the leukemia gene fusion; what factors predict pre-
leukemia at birth; how many children who never develop leukemia are born with the gene fusion; and how long
the gene fusion persists in childhood.
Establishing the true population prevalence and determinants of ETV6/RUNX1 gene fusion at birth is an essential
first step in reducing the burden of childhood ALL. Further, this project will be the first of its kind to monitor the
persistence of pre-leukemia in early childhood. The proposal is an exceptional opportunity to understand
childhood pre-leukemia, is robust in design using three independent studies, and leverages existing NIH
investment in pediatric epidemiology. Successful completion of the project will foster epidemiologic innovation
including cohort studies of infants at high risk for ALL, allowing us to fill significant gaps in our understanding of
the most common childhood cancer. Importantly, the work has the potential to translate into clinical monitoring
of ALL in high-risk populations.

Public health relevance
Project Narrative The ETV6/RUNX1 pre-leukemic clone is initiated in utero in some infants who go on to develop pediatric acute lymphoblastic leukemia, as well as a portion of healthy infants who do not develop cancer. We will determine the strength of association between birth with the ETV6/RUNX1 translocation and childhood leukemia risk and we will establish predictors of initiation and persistence of the ETV6/RUNX1 pre-leukemic clone into early childhood. This project will increase our understanding of childhood leukemia etiology and allow for the development of risk prediction studies.